Discipline C: Radiochemistry, Analytical Track 1: Food Defense

Project Summary/Abstract ? Track1 The overarching aim of this project is to support food defense efforts in the State of Colorado by establishing a radioanalytical measurements laboratory capable of monitoring human and animal food products for gamma-emitting radioactive contaminants. This laboratory will be established with the support from the Colorado Department of Agriculture (CDA), which will provide the animal food samples that will be analyzed in this laboratory. A minimum of twenty- five animal food samples per year provided by the CDA will be analyzed for gamma-emitting radioisotopes using high-purity germanium and sodium iodide detectors already available in the Health Physics program at Colorado State University. Suitable laboratory space will be dedicated to this effort and the required quality assurance and control system will be established to ensure accuracy of the results.